Identifying Endogenous Retroviral Factors in Viral Lymphomagenesis

PROJECT SUMMARY/ABSTRACT
Malignancy is the leading cause of mortality amongst people living with HIV (PLWH). Of these malignancies,
Non-Hodgkin lymphoma (NHL) is the most common hematological neoplasm affecting PLWH. Despite the
introduction of highly active antiretroviral therapy (ART), PLWH are 10-20 times more likely to develop NHL than
those without HIV. Epstein Barr Virus (EBV) is an oncogenic virus that is associated with the lymphomas most
commonly observed in PLWH. Active HIV infection can lead to Acquired Immunodeficiency Syndrome (AIDS) in
untreated people, and it is known that AIDS promotes the development of EBV+ lymphomas, termed AIDS-
defining cancers (ADCs), the effect of host factors, including endogenous retroviruses on lymphomagenesis in
immunocompetent PLWH treated with ART, remains to be explored. Work in the Cesarman and Nixon labs has
shown that EBV and HIV each hijack host cell signaling pathways upon infection to induce the expression of
endogenous retroelements, including as human endogenous retroviruses (HERV). To determine the
contributions of these viruses on lymphomagenesis, we will generate data from in vitro lymphoma models to test
the effect of EBV and HIV proteins on the expression of endogenous retroviral oncoproteins. Additionally, we will
perform bulk and single-cell sequencing of Diffuse Large B Cell Lymphoma (DLBCL) from PLWH to determine
the changes in cell populations of the tumor microenvironment (TME). We hypothesize that there will be unique
populations of EBV infected B cells with pre-malignant transcriptomic signatures that correlate with dysregulated
HERV expression, including expression of the HERVK(HML2) Np9 oncogene.
In Aim 1, we will determine the impact of EBV latency III LMP2A and extracellular HIV p17 variants on the
expression of the Np9 oncogene. We will perform stepwise molecular and cellular studies to determine the
translational impact of exogenous viral infection on the expression of this endogenous retroviral oncogene. We
will additionally perform multi-omic analysis to identify viral and host factors relevant to the transcriptional
machinery of virus-mediated Np9 oncogene expression.
In Aim 2, we will use our novel established single cell pipeline to determine locus-specific endogenous retroviral
transcription of DLBCL samples from PLWH. Preliminary data from our work in the Nixon lab strongly suggests
that we will be able to use the pipeline that we have developed to identify and quantify these HERV transcripts
from RNA-sequencing data. We will assess the relative cell populations of samples that are EBV+ to those that
are EBV- and determine the differences in host gene, retroviral and viral transcripts. Additionally, we intend to
validate these single cell findings with bulk RNA-sequencing from a larger cohort of EBV+/- fresh frozen tissue
of DLBCL from PLWH.

Public health relevance
PROJECT NARRATIVE Virus-associated malignancies may account for an estimated 15 percent of all human cancers worldwide, which represents a significant component of the global cancer burden. Both HIV and EBV have documented associations with a number of malignancies and people living with HIV are at a higher risk of developing cancer despite antiretroviral treatments. This study aims to identify and characterize novel interactions between exogenous viral factors and endogenous retroviral oncogenes that play an essential role in virus-associated cancers.